Center for Demography and Ecology

Project Summary/Abstract
This supplement requests one year of additional support for the Center for Demography and Ecology (CDE)
at the University of Wisconsin–Madison. CDE is a highly-productive population research center, with over 70
affiliates in over 25 departments across seven colleges conducting work that directly addresses the three
components of the Population Dynamics Branch scientific mission. CDE has held NICHD center grant
funding continuously since 1972, and this application requests continuation of that support under NICHD's
Population Dynamics Research Infrastructure Program (P2C). Support is requested for an Administrative
Core, a Development Core, and a Scientific and Technical Core. The center grant will continue to support an
integrated and interdisciplinary collection of scholars whose research spans the field of population science.
During the past five years, CDE has recruited many excellent young scientists and established scholars and
strengthened its ties across campus with departments, research centers and institutes in fields related to
CDE's research areas. Our research portfolio is now more diverse, more interdisciplinary in character, and
covers a greater portion of the life course than in the past. CDE affiliates conduct research in five primary
research areas: (1) Families and Family Change; (2) Health & Biodemography; (3) Inequality, Poverty,
Wealth, & Mobility; (4) Spatial & Environmental Demography; and (5) Gender & Reproductive Health. In
addition to innovative research in each of these areas, CDE researchers continue to collect and produce
high-quality data for use by the population research community, including a growing body of genetic and
biomarker data. Continued infrastructure support from NICHD will allow CDE to leverage substantial
commitments from the University, a large portfolio of individual research grants, and outstanding human and
organizational resources to promote innovative interdisciplinary research in population science.

Public health relevance
Project Narrative Population science plays a critical role in identifying changing population patterns and their implications for individuals, groups and societies. Increasingly, with new data and analytic techniques, population science can bridge social scientific, biomedical and environmental research in order to better understand the multiple and interactive factors that affect human health and wellbeing. CDE will continue to conduct, develop and disseminate innovative, interdisciplinary population research and to provide excellent training to the next generation of scholars.